Evaluating the role of SPAK and OSR1 kinases in glioblastoma chemotherapy resistance

Project Summary
Glioblastoma (GBM) is the most devastating brain neoplasm with high morbidity and mortality.
Despite multimodal treatment including surgery, radiotherapy, and chemotherapy, the disease
recurs and is fatal. Given its public health importance, there is an unmet need for new treatment
strategies to prolong patient survival while improving the quality of life. SPAK (SPS1-related
proline/alanine-rich kinase) and OSR1 (oxidative stress-responsive kinase) are stress-sensing
kinases that phosphorylate and activate NKCC and KCC ion co-transporters which are key
players in restoring intracellular Cl- and cell volume in response to cell stress. This is of
importance because cell volume decrease and reduction of total intracellular ionic strength (via
Cl- and K+) are the earliest stimuli that lead to apoptosis. Cancer cells can counteract pro-
apoptotic signals by using regulatory volume increase through SPAK/OSR1/NKCC1 activation.
Therefore, these kinases can serve as a resistance mechanism to cell death. On the other hand,
cell volume regulation is an essential mechanism for cell migration in the confined spaces in the
brain. Our preliminary data using genetic and pharmacological inhibition of SPAK/OSR1 shows
that these kinases decrease GBM cell migration, proliferation and tumor growth in vivo and could
serve as a mechanism of therapy resistance to chemoradiotherapy. However, SPAK/OSR1
function, mechanism, and therapeutic role in GBM remains unexplored. We hypothesize that
SPAK/OSR1 exerts oncogenic functions as a cell-stress resistance mechanism allowing cancer
cells to survive hostile environments and enhance GBM malignancy. The goal of this proposal is
to evaluate if SPAK/OSR1 serves as a mechanism of resistance to the standard of care. We will
evaluate the therapeutic efficacy of SPAK/OSR1 inhibition using a novel small molecule inhibitor
in combination with chemo-radiotherapy and describe the role of SPAK/OSR1 in tumor resistance.
Our long-term goal is to set the foundation for a research program that will study the relevance of
the SPAK/OSR1 pathway in GBM progression identifying druggable signaling pathways that
regulate GBM cell invasion and proliferation.

Public health relevance
Narrative Glioblastoma (GBM) is the most devastating primary brain tumor in adults, characterized by enhanced invasion and proliferation and therapy resistance. This project will evaluate the role and therapeutic implications of the SPAK and OSR1 kinases in GBM. Our long-term goal is to develop a research program focused on identifying druggable signaling pathways that regulate GBM cell invasion and proliferation.